Spinal Cord Associative Plasticity for Amyotrophic Lateral Sclerosis

Amyotrophic lateral sclerosis (ALS) is more prevalent in Veterans than civilians, leading to ALS being considered
a Service-Connected condition by the VA. ALS features incomplete degeneration of upper and lower motor
neuron pathways within the spinal cord, a circumstance resembling that of spinal cord injury (SCI).
Transcutaneous spinal cord stimulation (TSCS) has demonstrated remarkable potential to activate damaged
circuits after SCI to improve motor and autonomic function.
Partly funded by a prior RR&D SPiRE award (RX002527), we have preliminary data demonstrating that pairing
subthreshold cervical TSCS pulses with suprathreshold transcranial magnetic stimulation (TMS) pulses can
enhance hand muscle motor evoked potentials when the cortical pulse reaches the cervical spinal cord 0-5
milliseconds prior to the spinal pulse. This evidence for immediate facilitation of the response to one pair of
pulses suggests that if given repetitively, this approach could mediate spinal cord associative plasticity
(SCAP) outlasting the period of paired stimulation. We propose that increasing neural plasticity in this manner
could be applied as a method to strengthen volitional (cortical) motor output and/or to 'prime' weakened circuits
for improved responses to task-oriented exercise.
Both exercise and neuromodulation are understudied in ALS. Though not likely to cure the underlying disease
mechanism, these approaches have the potential to mediate symptomatic benefit. We strive to find better ways
to conduct disease-oriented research that may provide direct clinical benefit to research participants with
ALS and simultaneously increase scientific understanding. Additionally, most ALS clinical study entry criteria
heavily favor those at earlier stages of disease. Strict entry criteria are understandable from the scientific
perspective. However, we have repeatedly observed the frustration and rejection felt by individuals with ALS
who cannot enter clinical trials. Our proposed study does not restrict entry by time since symptom onset. We
thereby hope to produce more generalizable knowledge by performing a phased study:
1. Optimization: SCAP synaptic pairing interval and repetitive frequency pattern will be individually
optimized to enhance hand muscle excitability and dexterity. We hypothesize that pairs of stimuli with
TMS arriving at the cervical spinal cord up to 2 ms prior to TSCS, delivered in an ‘intermittent theta burst’
pattern, will produce the strongest facilitation of hand neural circuits.
2. Consolidation: Two-week programs of SCAP alone versus exercise alone versus SCAP plus task-
oriented hand exercise will be compared. We hypothesize that the combined intervention will result in
greater and longer lasting physiological and clinical benefits than either modality by itself.
There are currently no clinical studies in the world involving magnetic brain paired with phasic electrical spinal
stimulation for ALS. Therefore, safety needs to be meticulously tracked. Aside from detailed clinical safety
measures, we will analyze serum biomarkers drawn at baseline and various stages of the study to better
understand whether baseline levels of neurodegenerative, excitotoxic, inflammatory, and neurotropic
biomarkers associate with either beneficial or detrimental responses to SCAP and exercise interventions.

Public health relevance
Veterans are at higher risk than non-Veterans of falling ill with amyotrophic lateral sclerosis (ALS). As we await a cure for ALS in the future, we need more treatments now. We have shown that pairing electrical stimulation over the cervical spinal cord synchronized with magnetic stimulation over the brain can temporarily strengthen weakened nerve circuits between the brain and hand muscles in people with ALS. The current proposal will take the next step of customizing this intervention for each individual, then applying it repetitively in an attempt to achieve direct clinical benefit on hand strength and function. We will compare the effects of two-week programs of hand exercise versus paired brain-spinal stimulation versus the combination of exercise and stimulation. Not only will this project improve understanding of paired brain-spinal cord stimulation in ALS, but its eligibility criteria will also be more inclusive than most ALS studies, giving more Veterans an opportunity to participate in research aimed at treating this service-connected condition.